Active Growth, Active Life: Eliminating Biomechanical Barriers to Physical Activity through Growth-Period Exercise

PROJECT SUMMARY
Physical inactivity is a grave public health concern as a primary contributor to disease and mortality that also
imposes a massive burden in terms of health costs. Addressing these problems requires the removal of
barriers to physical activity, including biomechanical barriers originating within our own bodies. Humans and
non-human animals alike are more active in adulthood when they have had a more active childhood, but the
reasons for this are not well understood. We propose that physical activity during childhood promotes healthy
development of musculoskeletal structure that reduces the effort associated with movement, thus predisposing
adults to physical activity throughout their lifetimes. Previous work, including our own recent studies using an
avian animal model, supports this idea: The structure of muscles and bones has been shown to adapt to
loading that accompanies activity, and this plastic adaptation is especially pronounced during the growth
period. Further, there is evidence that animals with limited early-life activity have altered muscle mechanical
advantage and exhibit less spontaneous activity as adults. The purpose of the work proposed in this R01
application is to explore these connections between structure, function, and behavior using a rigorous multi-
level experimental approach that spans tissue-level analysis, locomotor analysis, and behavior analysis in
avian (guinea fowl) and mammalian (mouse) animal models, each of which offers distinct advantages.
Specifically, we will: (1) investigate the dose of early-life exercise necessary to produce lasting changes in
musculoskeletal structure, locomotor function, and adult behavior; (2) study the effects of the timing of exercise
onset in childhood on these outcomes; and (3) examine whether there are special benefits for early-life
physical activity in relation to adult-onset exercise. If successful, this work will change our understanding of the
factors influencing physical activity behavior, directly informing new interventions that improve activity-related
health throughout the lifespan.

Public health relevance
PROJECT NARRATIVE It is well known that physical inactivity is linked to poor health and lower quality of life; recent work has shown that how active an individual is during childhood can alter the structure of bones, joints, and muscles in such a way that the capacity for exercise as an adult would be affected. This project explores how growth-period exercise prescription can reverse the effects of inactivity by documenting altered anatomy, function, and ultimately the effects on adult exercise behavior. Fundamental knowledge arising from this work will allow us to optimize musculoskeletal structure and function through targeted physical activity in childhood to enhance lifelong health and mobility.